A Life-Course Approach to Assessing Effects of Environmental Exposures on Kidney Development

Project Summary
NYU Grossman School of Medicine and Erasmus University Medical Center jointly propose to evaluate how
organophosphate pesticides, glyphosate, phthalates and bisphenols contribute to renal risks in childhood and
adolescence. The incidence of chronic kidney disease (CKD) is steadily rising and synthetic chemicals are
increasingly understood to contribute to acute and chronic kidney injury. Case-control studies of populations
with high incidence rates have identified pesticide and herbicide exposures as risks, raising the question
whether developmental exposures may be even more impactful. Our own studies of children with CKD
(R01DK100307) have revealed modest declines in kidney function with increasing phthalate and bisphenol
exposures, accompanied by increases in oxidative stress. However, these findings do not contribute to our
understanding of the origin of CKD. A major limitation is the failure of our and other studies to account for the
developmental biology of the kidney and strong influence of perinatal/infant factors. The premise of the
present proposal is that intrauterine inflammatory processes disrupt nephrogenesis and that environmental
chemicals also impair renal parenchymal growth longitudinally during gestation and postnatal development via
oxidant stress. We further interrogate this hypothesis by examining phthalates, bisphenols, glyphosate and
organophosphate (OP) pesticides as modifiable risks. We will test these hypotheses in Generation R First, a
prospective, longitudinal multi-ethnic birth cohort with existing measurements of phthalate and bisphenol
exposure at three time points in pregnancy and three time points in childhood (5-6, 9-10 and 13-14 years) in
1405 mother-infant pairs (funded by R01ES022972 and R01ES032826). Organophosphate (OP) exposures
were measured in the same time points in pregnancy in a subsample of 776 (ZIAES103314). We therefore
propose to: add measurements of glyphosate and oxidative stress exposure in pregnancy and childhood at the
same six time points (n=1312 children with at least one measure of kidney size, eGFR or albuminuria);
complete the measurements of OP in pregnancy and childhood to permit mixture analyses that also consider
phthalates, bisphenols and glyphosate; and evaluate glomerular (albuminuria) and tubular injury (KIM-1,
NGAL) as well as functional renal mass (urinary epidermal growth factor, EGF) at the four time points in
childhood. Leveraging Generation R First for the proposed work presents substantial cost-efficiency, with
available measurements of kidney size, eGFR and albuminuria at ages 5-6, 9-10 and 13-14, and planned
measurements at 17-18 years of age. The proposal couples the expertise of an internationally renowned
environmental pediatrician (Trasande) with a life course epidemiologist (Jaddoe) who is PI of Generation R.

Public health relevance
Project Narrative We propose to study the effects of organophosphate pesticides, glyphosate, phthalates and bisphenols contribute to renal risks in childhood and adolescence. Significant associations identified here could be the basis for studies of interventions to reduce exposures at time periods identified to be important.